Developmental mechanisms underlying visual and auditory topographic map alignment and accurate spatial orienting behavior

Across species, multisensory integration (MSI) is used to accurately and rapidly localize objects in
the environment. This process is presumed to rely on the correct organization of sensory inputs into
topographically aligned maps of egocentric space. However this idea has not been rigorously tested.
MSI and spatial orienting behaviors are compromised in many developmental disorders including
Autism, Schizophrenia and ADHD, highlighting the significance of understanding the developmental
mechanisms that establish effective MSI-dependent behaviors.
The overall objective of this application is to determine the mechanisms used to integrate visual and
auditory maps of location in the mouse superior colliculus (SC) and identify the behavioral
consequences to animals deficient in these mechanisms. The central hypothesis is that sensory
experience is used to align auditory and visual maps of space in the SC; furthermore, accurate
alignment of the two maps is required for effective MSI and robust natural spatial orienting behavior.
Aim 1 seeks to determine both the developmental window in which MSI forms and the critical period
of sensory influence. We will present a wake mice with spatially restricted visual and auditory stimuli
while recording neuronal responses in the SC using high-density probes. Analyzing this data will
determine the spatial receptive fields (RFs) of visual, auditory and visual/auditory multimodal neurons.
This will be done at key developmental stages plus or minus visual or auditory deprivation.
The goal of Aim 2 is to quantify how developmental changes in multisensory experience alter
natural stimulus localization behaviors. Mice innately hunt insects and their ability to capture them is
most efficient when they have access to multisensory cues. Of note, orienting behavior during prey
capture is disrupted in mouse models of ASD. Prey capture behaviors such as time to cricket detection,
spatial accuracy and precision of pursuit, and time to capture success will be measured in mice at
different ages and in those deprived of early vision or audition. This aim will reveal the role that sensory
experience plays in generating natural localization behavior.
Experiments in Aim 3 will test the longstanding hypothesis that the alignment and integration of
visual and auditory inputs in the SC rely on the visual map as a template. We will record the auditory and
visual response properties as in Aim 1 from two populations of mice: those with scrambled or duplicated
visual map topography via perturbations in EphA/ephrin-A signaling or shifted via prism goggles. We can
then determine if the auditory map rearranges to align and integrate with the duplicated, scrambled or
shifted visual map and, if so, how these changes lead to altered orienting behavior during prey capture.

Public health relevance
The proposed research is relevant to public health because integrating information from different sensory modalities is a fundamental but essential brain function, and, sensory integration deficits are prominent symptoms in people with autism, schizophrenia, and ADHD. The goal of this research plan is to identify the mechanisms used during development to create the circuitry responsible for sensory integration in the mouse superior colliculus, a midbrain sensory integrative structure, and determine the consequences to behavior when integration is disrupted. These findings will provide fundamental knowledge that will enable researchers to better understand and treat disorders of sensory integration.